Alzheimer's Disease Screening Using RNA TALENs and RNA Reprogramming

DESCRIPTION (provided by applicant): Methods for controlling cell-type by dedifferentiation, directed differentiation, and transdifferentiation or direct reprogramming have enabled the generation, in the laboratory, of tissue-specific, patient-specific cells from small, non-invasive skin samples. However, critical roadblocks have so far prevented these methods from being used to generate large screening libraries. Existing cell-reprogramming technologies are slow and inefficient, using either integrating viruses, which carry risks of insertional mutagenesis and spontaneous oncogene reactivation, or non-viral vectors with even lower efficiencies. Factor Bioscience has developed the first rapid, reliable, DNA-free technology for reprogramming adult cells. In this project, we will apply this technology to generate a library of cells capable of generating neurons from patients with and without Alzheimer's disease. Furthermore, we will use our patented gene-editing technology to confer Alzheimer's- associated mutations to healthy patient samples, creating the first isogenic library for screening drugs to treat or preven Alzheimer's disease. PUBLIC HEALTH RELEVANCE: This project will develop the first library of gene-edited neurons developed from patient cells in order to model Alzheimer's-disease-associated mutations in an isogenic background. The results of this project will enable more accurate drug screening for the treatment and prevention of Alzheimer's disease.

Public health relevance
This project will develop the first library of gene-edited neurons developed from patient cells in order to model Alzheimer's-disease-associated mutations in an isogenic background. The results of this project will enable more accurate drug screening for the treatment and prevention of Alzheimer's disease.